Shape Analysis Toolbox: From medical images to quantitative insights of anatomy

PROJECT SUMMARY Three-dimensional shape lies at the core of understanding the physical objects that surround us. The Shape AnaLysis Toolbox (SALT) was created to be a dissemination vehicle for advanced shape modeling and analysis methodology as an open-source, comprehensive and freely distributed software. Over the past four years, we have been successful in increasing the ease of use and effectiveness of state-of-the-art shape analysis methodology for biomedical researchers in need of such techniques. We now propose necessary and novel enhancements to our methods and our dissemination model in order to continue maximizing the success of SALT. We will also modify the architecture of SALT to better integrate biomedical imaging research workflows by improving the efficiency and scripting capabilities so SlicerSALT can be deployed in batch mode for large-scale sequential computations. We will also shift our focus from shape modeling into state-of-the-art statistical shape analysis methodologies, necessary to serve clinical applications and to increase the interpretability of shape biomarkers. We will continue to disseminate novel example applications that best demonstrate how to use our tools to perform impactful research and will provide fully digital documentation for user support. The ultimate goal of SlicerSALT is to maximize the potential benefits of the geometric information contained in medical data and to expand its use beyond simple visualization to support clinical research.

Public health relevance
PROJECT NARRATIVE Slicer Shape AnaLysis Toolbox (SALT) was developed as an open-source, free comprehensive software that allows biomedical scientists to precisely locate shape changes in their imaging studies. This proposal is designed to increase the continued success of SALT by recognizing that shape models and dynamic anatomical changes are challenging to interpret despite quantification of the geometry of physical objects. We will address this need by incorporating state-of-the-art and interpretable shape statistics methodology into SALT and new driving biological problems to illustrate their utility while continuing to provide effective user support.